The Role of TULP1 in Photoreceptor Cells

DESCRIPTION (provided by applicant): Retinitis pigmentosa (RP) incorporates a large number of inherited retinal disorders characterized by photoreceptor degeneration. RP is genetically and phenotypically heterogeneous, affecting over 1 million individuals worldwide. Mutations in a gene called TULP1 underlie an early-onset and severe form of autosomal recessive RP. Tulp1 is a protein exclusive to photoreceptor cells, and although the function of Tulp1 remains elusive, there is evidence from the murine model lacking Tulp1 that it plays a role in intracellular protein movement in multiple compartments of the photoreceptor. In tulp1-/- mice, prior to photoreceptor degeneration, rod and cone opsins are mislocalized, and rhodopsin-bearing extracellular vesicles accumulate around the inner segment (IS), indicating that Tulp1 is necessary for the transport of proteins to the outer segment (OS). These mice also have a synaptic malformation that precedes photoreceptor degeneration and most likely interferes with the proper development of post-receptoral neurons. The absence of Tulp1 results in abnormalities that affect structure and function in multiple retinal sites, as well as causing distinct abnormalities in separate photoreceptor compartments. This suggests that it either performs a general role throughout the photoreceptor or participates in multiple distinct pathways. Based on our published work and preliminary data, the central hypothesis of this proposal is that Tulp1 is a component of the molecular machinery involved in the vesicular movement of proteins in two photoreceptor cell compartments. Our long-term objectives are to understand the physiological function of TULP1 and the pathogenic mechanism responsible for retinal degeneration associated with TULP1 mutations. Experiments designed in Aim 1 will identify Tulp1 interacting partners by proteomic analysis, comparing IS-specific to synaptic-specific interactomes. In Aim 2, molecular dissections of the IS and synapse lacking Tulp1 and expressing mutant forms of TULP1 that cause RP will be conducted to probe for structural or spatial disturbances. Attention will focus on proteins that bind Dynamin-1, a neuronal-specific protein that is essential for vesicular trafficking. Elaborating on the Tulp1/Dynamin-1/Actin interaction, which we believe composes the core of Tulp1 functional complexes, will unlock the mechanism of action of Tulp1. Aim 3 will analyze vesicle cycling in the tulp1-/- photoreceptor synapse. This will be accomplished using styryl dye photoconversion followed by electron microscopy. At the successful completion of this work, we will position Tulp1 in a functional context and define its mechanism of action. Our results will provide insight into the functional organization of photoreceptor protein transport pathways, as well as insight into the perturbation of retinal function associated with TULP1 mutations. Finally, this project has potential for significantly impacting an important aspect of photoreceptor biology relevant to human retinal disease. PUBLIC HEALTH RELEVANCE: The goal of this research project is to identify the function of Tulp1, a photoreceptor-specific protein proposed to be involved in protein movement. Mutations in TULP1 cause an early-onset and severe form of retinitis pigmentosa, an inherited form of blindness. Results will provide insight into the pathological mechanisms causing photoreceptor degeneration and significantly impact an important aspect of photoreceptor biology relevant to human retinal disease.

Public health relevance
Project Narrative. The goal of this research project is to identify the function of Tulp1, a photoreceptor-specific protein proposed to be involved in protein movement. Mutations in TULP1 cause an early-onset and severe form of retinitis pigmentosa, an inherited form of blindness. Results will provide insight into the pathological mechanisms causing photoreceptor degeneration and significantly impact an important aspect of photoreceptor biology relevant to human retinal disease.